Molecular Biology Of Varicella Zoster Virus Infection

Varicella-zoster virus (VZV) establishes latency in human sensory and cranial nerve ganglia during primary infection (varicella), and the virus can reactivate and cause zoster after primary infection. At present, one varicella vaccine and one zoster vaccine are licensed and available for use in the United States. We have been collaborating with Christopher Pleyer in the National Heart Lung and Blood Institute to look at the response of patients with hematologic malignancies to the zoster subunit vaccine.